Transcriptional differences in human postmortem brain tissue correspond with impulsive behavior in mood disorders

Project Summary
Mood disorders, characterized by reduced affect, can result in and diminished quality of life and are the leading
cause of disability worldwide. Within these disorders, impulsive behavior emerges as a crucial endophenotype.
Elevated levels of impulsivity in individuals with mood disorders are associated with poorer treatment
adherence, worse health outcomes, and an increased risk of suicide. While previous genome-wide association
studies have linked certain genes to impulsive behavior, there is a lack of research examining the differential
gene expression related to impulsivity in humans, particularly those diagnosed with mood disorders. The
current research application aims to address this gap by investigating transcriptomic and epigenetic differences
in the dorsolateral prefrontal cortex, orbitofrontal cortex, anterior cingulate cortex, and nucleus accumbens of
individuals diagnosed with mood disorders alongside healthy control subjects. Additionally, the study will
integrate whole genome sequencing data from individuals diagnosed with mood disorders and controls
subjects to test association signals. This comprehensive approach will provide valuable insights into the
genetic mechanisms underlying impulsivity in mood disorders, improving our understanding and creating
targeted treatment options. Based on preliminary data generated from this laboratory, we hypothesize that
specific genetic and epigenetic alterations targeting key genes associated with neuroinflammation and synaptic
structure within the dorsolateral prefrontal cortex (dlPFC), orbitofrontal cortex (OFC), anterior cingulate cortex
(ACC), and nucleus accumbens (NAc) play a causative role in impulsive behavior in individuals with mood
disorders. The proposed study consists of three aims, each contributing to the understanding of genetic and
epigenetic factors underlying impulsive behavior in mood disorders. Aim 1 will continue the analysis of RNA
expression in key brain regions of individuals with mood disorders and controls. By incorporating samples from
various brain banks, the study aims to enhance statistical power, minimize sampling bias, and uncover new
differentially expressed genes. Aim 2 will focus on exploring differential DNA methylation patterns in the same
individuals studied in Aim 1. Understanding region-specific methylation data will shed light on its role in mood
disorders and reveal heritable mechanisms of gene regulation. Aim 3 will create comprehensive network and
pathway analyses based upon lists of genes generated from pilot data and previously published data, as well
as from Aims 1 and 2. This will provide greater insight to relationships among genes than lists of single genes.
Furthermore, this aim will explore connections with the results from Aims 1 and 2 at the molecular level. Each
aim contributes to the broader picture of how genetic and epigenetic differences can jointly influence impulsive
behavior within the context of mood disorders and the integration of these independent aims will lead to a
comprehensive understanding of the underlying mechanisms driving impulsivity in mood disorders.

Public health relevance
Project Narrative High levels of impulsive behavior have been linked to worse health outcomes for individuals with mood disorders including suicide and poor medication adherence. Despite impulsive behavior being highly heritable, the underlying genetic mechanisms of impulsivity are poorly understood. An improved understanding of the genetics contributing to impulsive behavior will open the way for better, more personalized treatment and identify novel therapeutic targets for medication development.